Neuroimaging Acquisition and Analysis (NA2)

ABSTRACT
Neuroimaging Acquisition and Analysis (NA2) Core
Cognitive Neuroscience of Development and Aging (CoNDA) Center
Cognitive neuroscience research with human subjects requires the integration of cognitive psychology and
neuroscience to identify the brain substrates of different cognitive processes and behaviors. The Neuroimaging
Acquisition and Analysis (NA2) Core of the Cognitive Neuroscience of Development and Aging (CoNDA) Center
was part of the CoNDA Phase I grant and will continue in Phase II. In that role, NA2 will continue to support
Research Project Leads (RPLs) and Pilot Project Investigators (PPLs) who are conducting human subjects
research with healthy and non-healthy children and adults; the facilities comprising the NA2 Core are of course
also available to other investigators. The NA2 Core will provide a full complement of cutting-edge neuroimaging
capabilities along with expertise in the collection, storage, processing, analysis, and interpretation of
neuroimaging data. The NA2 Core is composed of two “sub-cores” supporting the collection of magnetic
resonance imaging (MRI) data and magnetoencephalography (MEG) data, respectively. For MRI data collection,
CoNDA’s NA2 Core includes UNMC’s research-dedicated MRI facility, a core that houses a 3T Siemens Prisma
MRI instrument equipped to collect data in structural, functional, diffusion, spectroscopy, and still further MR
modalities. For MEG data collection, CoNDA’s NA2 Core facilitates research utilization of a MEGin Truix Neo
MEG instrument owned by Nebraska Medicine (UNMC’s clinical counterpart). CoNDA’s NA2 Core was
implemented from the inception of the Center, and research utilization by CoNDA and campus investigators has
grown tremendously since that time. The NA2 Core will be led by Dr. David E. Warren (director, MRI lead) and
Dr. Valentina Gumenyuk (co-director, MEG lead) with facilitation of core activities by dedicated staff.